VIRUSES AND THE IMMUNE RESPONSE

Both the humoral and cellular arms of the immune response contribute to control of virus infections. Ectromelia, an orthopox virus infection of mice has been selected as a model system for studying host-virus interactions. It was found that Ly-2+ T cells are sufficient for in vivo resistance to this virus and that in vitro secondary responses to vaccinia are effected by interactions between Ly-2+ helper and effector cells. Interleukin-2 appears to mediate the interactions between these subsets of T cells.